Application of single-cell trajectory analysis in single-cell transcriptomics to elucidate the biology of lung pericytes in injury, repair, and regeneration

ABSTRACT
Pericytes have been implicated in inflammation and fibrosis in a number of organs. Data from
transcriptomic analyses of activated cultured lung pericytes reveal upregulation of multiple
biological pathways including inflammation, angiogenic processes, and cell migration. The goal
of this project is to understand the functional plasticity of lung pericytes throughout injury and in
lung repair. We are interested in how lung pericytes modulate lung repair in lung fibrosis through
angiogenesis and myofibroblast differentiation. In Aim 1, we propose to use state-of-the-art
single cell trajectory analysis on single-cell transcriptomic data to describe the cell fate of lung
pericytes from acute lung injury to fibrosis. In Aim 2, we propose to study selected stromal
subpopulations derived from pericytes and non-pericyte-derived myofibroblasts during fibrosis to
examine their functional differences ex vivo.

Public health relevance
PROJECT NARRATIVE Inflammation and fibrosis in the lung lead to significant mortality and morbidity in many disease states such as acute lung injury and idiopathic fibrosis. In this proposal, we will investigate how specialized cells in the lungs, termed pericytes, mediate inflammation, vascular dysfunction, scar formation, and other cellular processes that affect lung damage and normal regeneration.